Vanderbilt AUD Research and Education Center (VAREC)

The central thesis of the Vanderbilt AUD Research and Education Center (VAREC) is
that effective treatment requires recognition of, and deep understanding of the distinct
symptoms, etiologies, and disease progressions that underlie what is unitarily referred to
as Alcohol Use Disorder (AUD). We propose a reverse translational “precision
neuroscience” approach. We will dissect AUD endophenotypes to generate human
circuit construct validated animal models that we will utilize to gain mechanistic insights
and test therapeutic targets. VAREC will consist of 4 research components (Projects1-4)
supported by Administrative and Research cores, as well as a Dissemination core.
Project 1 (Blackford) expands our initial human imaging studies into a deep sampling
approach to analyze BNST and network connectivity in AUD across the abstinence
timespan, exploring individual differences in these networks with AUD relevant domains
such as anxiety and depression. Project 2 (Winder) will build off an already active
collaboration with Project 1 to perform reverse translational mouse studies to test
emergent hypotheses on insula-BNST and hippocampal-BNST connectivity in mouse
models of AUD, and to explore potential time-dependent therapeutic approaches during
abstinence. Project 2 will also perform specific broad-scale mouse brain imaging studies
to define network nodes for Project 1 to explore in years 4-5. Project 3 (Calipari) will
explore whether alterations in negative affect observed in Project 1 and Project 2 lead
directly to functional enhancement of negative reinforcement-oriented circuitries and
behavior. Finally, Project 4 (Siciliano) will engage in deep phenotyping of individual
differences in mouse behaviors correlated with compulsive drinking behavior, working
across the projects to identify populations of precise behaviors that are predictive of
compulsive ethanol seeking. Projects 2 and 4 explore therapeutic targets through
analysis of endocannabinoid and dynorphin signaling. The project interactions will be
coordinated by an Administrative core. A Research core will provide mice that have
undergone one of two voluntary alcohol exposure models, Chronic Drinking-Forced
Abstinence (CDFA) or Structured Tracking of Alcohol Reinforcement (STAR). It will also
provide research infrastructure and computational support. Through a Dissemination
core, VAREC will play an important role in public health by activities aimed at
destigmatizing AUD treatment seeking and increasing prevention through novel nearpeer
targeting of adolescents. This core will also allow VAREC to serve as a resource to
the alcohol research community to facilitate mainstream incorporation of cutting-edge
tools into the field.

Public health relevance
PROJECT NARRATIVE The Vanderbilt AUD Research and Education Center (VAREC) will perform iterative forward- and reverse-translational research exploring key circuitries underpinning specific components of Alcohol Use Disorder (AUD). VAREC will also engage the public through near-peer and podcast-style educational approaches to destigmatizing discussion of AUD and engage the alcohol research community through short courses aimed at incorporation of modern neuroscience technologies across the neuroscience of AUD research landscape.